Clinical development of a colon-targeted butyrate tablet to evaluate effects on cholesterol and trimethyl amine oxide in subjects at risk for cardiovascular disease

PROJECT SUMMARY
Cardiometabolic disease (CMD), which includes cardiovascular disease, type 2 diabetes (T2D), and stroke, is
the number-one cause of death in the world. Drugs currently used to treat CMDs by lowering LDL-C, such as
statins and proprotein convertase subtilisin/kexin type-9 (PCSK9) inhibitors, are either not completely effective,
have numerous side effects, are very expensive, or are delivered by injection. In addition, these drugs do not
reduce the incidence of T2D and insulin resistance. Thus, there is a critical need for new therapies that treat the
various conditions of CMD and that address the shortcomings of current treatments. Secretion of gut hormones
in response to nutrient ingestion is critical for the proper management of lipids, glucose, and appetite; however,
gut hormone responses are impaired in patients with hyperlipidemia, diabetes, and obesity.
BioKier is developing the first orally administered therapeutic, BKR-017, that restores gut hormone secretion in
the colon of patients with CMD. The active ingredient is butyrate, one of the most important natural activators of
gut hormone release. BioKier’s approach is to improve the delivery of butyrate to the active site of gut hormone
secretion, the colon, and thus improve gut hormone secretion in conditions of CMD. This approach is a significant
advance on the use of other formulations of butyrate that do not specifically target the colon and on injectable
GLP-1 analogs that have efficacy but also have dose-limiting side effects. BKR-017 is designed to address
deficiencies in gut hormone secretion, improve cardiometabolic conditions, and, due to its novel mechanism of
action, complement the actions of existing therapies.
The overall aim of this Phase I project is to demonstrate the safety of BKR-017 in a Phase 1 clinical trial. Safety
in Phase 1 is the first step in the clinical development of novel drugs under an IND. Successful completion of this
Phase I SBIR project will position BKR-017 for a Phase II SBIR application in which we plan to propose a Phase
2 clinical trial to investigate the efficacy of BKR-017 in lowering LDL-C levels in subjects with elevated LDL-C
and the associated risk of cardiovascular events. Pilot studies by BioKier indicated that BKR-017 significantly
reduced total cholesterol, LDL-C, non-HDL-C, apolipoproteins, trimethylamine N-oxide (TMOA), and fatty liver
biomarkers, which are all indicators of increased cardiovascular risk. However, these studies were conducted in
subjects selected for T2D but not for hyperlipidemia. These results suggest that BKR-017 will have even more
significant effects in hypercholesterolemia patients, many of whom cannot lower their LDL-C to safe levels with
statin use alone.
Development of BKR-017 along the path of prescription drug approval will significantly increase the value of the
drug and its appeal to large corporate partners who have the capacity to commercialize it. BioKier has
commissioned a market analysis that indicates that there is a large and growing market for new drugs that are
effective in patients who are resistant to, or unwilling to use, statins. Other options are not widely accepted
because of cost, inconvenient administration, and/or side effects.

Public health relevance
Narrative Cardiometabolic diseases are major health risks that are increasing in all parts of the world. Currently available treatments are limited because they do not work well, cause painful side effects, are difficult to take (require injections), and/or are invasive and expensive. In order to provide a safer and more effective alternative, BioKier has developed an orally deliverable, colon-targeted prescription product containing a natural active ingredient that is designed to improve cardiovascular disease-related conditions, including high cholesterol.